BLRD Research Career Scientist Award Application

Aging is the greatest risk factor for many chronic diseases including cancer, neurodegeneration, diabetes,
and heart disease. Currently, roughly half of the VA population is aged 65+ years, and in the next ten years,
more than 3 million of these veterans are expected to be over 75. Thus, studying genes that regulate aging
and aging-associated pathologies is critically important for biomedical advancements to benefit veterans’
health. This research program investigates two such genes, SIRT6 and SIRT7, which are “master
regulators” of many changes in aging tissues, such as DNA damage, metabolic and oxidative stress,
cellular senescence, and inflammation. Our projects study how decreased activity of these genes may
contribute to pathologies in cardiovascular and liver disease, diabetes, obesity, and many cancers, and how
activating these genes could protect against these pathologies. By identifying pathways that can be targeted
for therapy, this research can directly impact the health of the Veteran population.
.

Public health relevance
Aging is the single greatest risk factor for many chronic diseases and thus is a major contributor to morbidity in the VA population. Our overarching research goal is to understand how chromatin regulatory mechanisms influence nuclear and epigenetic programs, and how de-regulation of these mechanisms contributes to aging and disease. We focus on the mammalian SIRT6 and SIRT7 genes, members of the evolutionarily conserved “Sirtuin” gene family that regulates lifespan, metabolism, and stress resistance in many organisms. My lab has been at the forefront of studying the molecular mechanisms of SIRT6 and SIRT7 and their links to aging, cancer, and stress-resistance. We have pioneered biochemical and genomic approaches that established that SIRT6 and SIRT7 are highly selective histone deacetylase enzymes and identified their first known physiologic substrates. Our discoveries opened up the field for functional characterization of these hitherto orphan enzymes, by my lab and many others. We uncovered novel mechanisms of SIRT6 in preventing genomic instability, telomere dysfunction, DNA damage, heterochromatin dysfunction, aging-related epigenetic programs, and cellular senescence. We also elucidated functions of SIRT7 in regulating epigenetic oncogenic programs, tumor growth and metastasis, metabolic homeostasis, and non-alcoholic fatty liver disease. We have also had a longstanding interest in understanding cellular senescence and its roles in aging and age-related disease pathologies. We have provided many insights into novel triggers of cellular senescence and their regulation by SIRT6 and SIRT7, including heterochromatin defects and accumulation of pathogenic transcripts from non-coding, repetitive DNA sequences. Our ongoing research activities continue to probe the biological functions of SIRT6 and SIRT7, focusing in several areas: (1) Elucidate novel biochemical activities and substrates, molecular interactions, and genomic and epigenomic targets of SIRT6 and SIRT7; (2) Determine the effects of activating or inhibiting SIRT6 and SIRT7 on aging processes in cellular systems and in vivo mouse models; (3) Determine if increased levels of SIRT6 or SIRT7 can protect against pathologies of aging and potentially extend lifespan; (4) Discover novel mechanistic links of these genes to diseases of high impact to the VA patient population including metabolic, inflammatory, neurodegenerative, musculoskeletal, and neoplastic disorders. Importantly, in addition to elucidating the specific functions of SIRT6 and SIRT7, our research on these genes continues to address fundamental questions in the biology of aging, including: (1) Molecular mechanisms of genomic instability, cellular aging, and immunosenescence, and the physiologic impacts of these processes on functional changes of aging and disease; (2) The potential for increased activity of SIRT6 or SIRT7, using in vivo mouse models, to protect against aging-related pathologies and improve health; (3) Epigenetic mechanisms in aging and cancer biology, which, unlike genetic mutations, can be reversible and offer potential targets for developing novel therapeutic strategies; (4) Novel mechanistic and physiologic interplay of metabolic changes and pathologies of aging; (5) Overlapping or opposing molecular processes in aging physiology and cancer. Together, our work has a broad impact on research into molecular mechanisms of aging, metabolic disorders, cancer, and other aging-related pathologies, and promises to continue to provide new insights that may be translated into therapeutic strategies for diseases that impact Veterans’ health. .